ANALYSIS OF B CELL DEVELOPMENT IN TRANSGENIC MICE EXPRESSING REARRANGED IG

Summary of work: A point mutation in the pleckstrin homology domain of the mouse Bruton's tyrosine kinase (btk)gene results in an X-linked immune defect, Xid, characterized by immunological unresponsiveness to polymeric carbohydrate antigens. In Xid mice, B cells specific for phosphocholine (PC) do not develop in peripheral lymphoid tissues because they either fail to be positively selected from the marrow or they are clonally deleted via an antigen-driven, receptor-mediated process. Over-expression of the bcl-2 gene allows PC-specific B cells to survive and mature in Xid mukappa anti-PC transgenic mice, but PC-specific B cells are not rescued by bcl-2 in Xid mu-only transgenic mice. The failure of bcl-2 to rescue PC-specific B cells in mu-only transgenic mice suggests that either it does not correct the btk defect in the antigen-driven selection process that occurs in pre-B and/or in very immature B cells or that a btk-dependent proliferative phase is required for the selection and amplification of the PC-specific B cells in mu-only transgenic mice. The rescue of PC-specific B cells in mukappa transgenic mice indicates that bcl-2 can alter receptor-mediated B-cell selection at late stages in B-cell development. The rescued PC-specific B cells in Xid male mice do not exhibit an altered proliferation profile in response to B cell stimulating agents compared to B cells from unmanipulated Xid mice; thus, they fail to respond to soluble anti-mu or PC-Dextran, but they proliferate in response to PC, anti-mu or anti-id conjugated to Sepharose. Mice expressing transgenes encoding for M167 mukappa anti-PC antibody have been crossed and back crossed to Rag-2 knockout (Rag-/-) mice. Large numbers of B cells expressing anti-PC receptors develop in normal mice (Rag+/+), however, the development of these B cells is arrested in the bone marrow of the Rag-/- mice. In these recombinase deficient mice, the PC-specific B cells appear to be tolerized and their development arrested at check point one, i.e. they appear to have down regulated their surface receptors and are undergoing apoptosis in the bone marrow. Coexpression of the mukappa anti-PC transgenes with the bcl-2 oncogene in the Rag-/- mice results in rescue of B cell development in the bone marrow and large numbers of B cells can be found in the peripheral lymphoid tissues. However, these cells may still bearrested at check point two in that few of these B cells develop into mature CD23+ B cells. These data suggest that PC-specific B cells are autoreactive and escape clonal deletion in normal mice by a process of non-allelic exclusion. Coexpression of a lambda L-chain with the muk anti-PC transgenes in Rag-/- mice also rescues the B cells and result in low levels of serum ant-PC. When the muk anti-PC transgenes are expressed in a kappa knockout background, all B cells express a lambda L-chain in addition to the muk anti-PC Ig-receptors.